Investigating The Role Of The Maternal Androgen Milieu On Placental Function: A Potential Mechanism For Programming Of Fetal Growth Restriction And Cardiometabolic Dysregulation In Adulthood

Project Summary
Early prenatal exposure to sex steroids in utero has been shown to alter fetal developmental
trajectory and induce cardiometabolic pathologies in adulthood. Several preclinical studies have
shown that maternal androgen exposure is associated with reduced fetal growth and development of
cardiometabolic disorders in the adult offspring. During pregnancy, the placenta is the main organ
supplying nutrients, oxygen, and hormones from mother to fetus. Indeed, adverse fetal outcomes and
programming of long-term health risks are known to have placental origins. Given that androgen
receptors are expressed in human placenta, it has been proposed that androgens can modify normal
placental function. Thus, these observations highlight the plausibility of placental compromise in
pregnancies exposed to excess androgens, which may be a mechanism for programming of fetal
growth restriction and subsequent cardiometabolic dysregulation in adult life
This research proposal will investigate the relationship of maternal androgens during pregnancy with
pathologic markers of placental function and determine their impact on predicting cardiometabolic
diseases in adulthood among mother-offspring New England participants of the historic Collaborative
Perinatal Project (1959-1966). Given the sex differences in the anatomy and growth of the placenta, it
is also imperative to understand how changes in placental function impacts male versus female
offspring in response to prenatal androgen exposure. Thus, this proposal will also investigate the sex
differences in the effects of prenatal androgens on the placenta which has not be adequately
addressed in previous studies. Understanding the influence of prenatal androgens on the placental
system could lead to new sex-specific therapeutic approaches to target placental dysfunctions during
pregnancy and improve the health of mothers and their offspring across the lifespan.
Dr. Grace Huang (the PI) is an Assistant Professor of Medicine at Brigham and Women’s Hospital
and Harvard Medical School. Her K08 studies have already provided longitudinal evidence in a
human model that alterations in the gestational androgen milieu can have life-long programming
effects on the metabolic health of the offspring that is sex-dependent. The proposed R03 project will
build upon these findings and examine the sex-dependent impact of prenatal androgens on the
placenta, as a potential mechanism for long-term programming of adult cardiometabolic diseases.
These will be secondary analyses of data already collected that the PI has access to and familiarity
with analyzing. Together, the results of these studies will provide strong preliminary data supporting
an R01 application to further investigate the androgen-mediated mechanisms and epigenetic markers
involved in early programming of adult CVD and their underlying sex differences across the lifespan.

Public health relevance
PROJECT NARRATIVE Several studies have demonstrated that early prenatal exposure to androgens in pregnancy can lead to the development of cardiovascular and metabolic diseases in later adult life. As the main organ supplying nutrients, oxygen, and hormones from mother to fetus, this research will take a life-course approach to investigate the effect of maternal androgens during pregnancy on the placenta and determine their impact on predicting cardiometabolic diseases in adulthood. Discoveries made through this research is relevant to the NHLBI’s mission to understand the mechanistic role that prenatal androgens play in the development of cardiovascular disease, and may ultimately lead to new therapies targeting placental dysfunctions during pregnancy to improve the health of mothers and their offspring across the lifespan.